Leadership, Planning and Evaluation

The Roswell Park Cancer Comprehensive Cancer Center planning and evaluation process is overseen by the
Cancer Center Director, Dr. Candace Johnson, who is also the President and CEO. Planning and Evaluation
efforts serve as the framework for effective internal and external advice, developing and implementing the
strategic planning process, setting priorities, overseeing shared resources, research programs, and clinical
operations. Strategic planning and ongoing evaluation is critical to the success of the Cancer Center in making
progress towards its scientific, clinical, prevention and education mission. The Executive Council and the
CCSG Steering Committee are the central decision-making and internal advisory bodies, with the goal to foster
and encourage research productivity, promote interaction and collaboration, and take maximum advantage of
institutional strengths and unique scientific opportunities. The continuous cycle of planning and evaluation
allows leaders to make adjustments to priorities and resource allocation, develop future plans.
During the current funding period, a comprehensive strategic planning and evaluation effort was undertaken for
the Center. This led to a five-year CCSG and clinical strategic plan that robustly aligns programmatic initiatives,
capital projects, and organizational priorities for the Cancer Center with a financial plan; and further integration
of the clinical and research missions. External and internal advisory groups provided exceptional guidance and
recommendations to the senior leaders. Besides the Executive Council and the CCSG Steering Committees,
the CCSG External Advisory Board, program-specific advisory boards, Senior Leadership Group, Shared
Resource Advisory Committees, individual program meetings and retreats, and Disease Site Research Group
provide multiple forums to solicit and discuss feedback and critique to inform and improve the cancer center.